Understanding programs of invasion and metastasis in head and neck cancer

PROJECT SUMMARY
Intra-tumoral heterogeneity in human cancers is associated with poor treatment response and prognosis. Head
and neck squamous cell carcinoma (HNSCC) is a strikingly heterogeneous tumor, with over 550,000 new cases
per year. Unfortunately, this heterogeneity represents a major challenge in targeted therapy and treatment
responses, with detailed maps of intra-tumoral heterogeneity just starting to be defined. During my Ph.D. training
with Dr. Azad Bonni, I studied normal processes of brain development using sophisticated biochemistry
techniques 1,2,3,4, which inspired me to understand the signaling pathways that drive specific biological programs.
I applied these skills to studies of glioma, ultimately, defining a dual role for the transcription factor STAT3 as a
tumor suppressor and an oncogene 5,6,7. For my post-doctoral training, I joined the laboratory of Dr. Bradley
Bernstein, an expert in transcription, epigenetics, and innovative technology, to combine my interests in tumor
heterogeneity with my clinical interests in head and neck surgical oncology. Using single cell RNA-seq, we
defined the first atlas of HNSCC, identifying a partial epithelial-to-mesenchymal (p-EMT) program associated
with lymph node metastasis, lymphovascular invasion, and extracapsular extension8. We also refined tumor
subtyping from bulk RNA-seq approaches such as the Cancer Genome Atlas by leveraging our single cell
profiles. The objectives of this proposal are to (1) determine expression heterogeneity within 2D and 3D head
and neck cancer models and identify suitable models of p-EMT, (2) investigate the regulatory influence of cancer-associated fibroblasts and their ligands on malignant cancer cell states, including the underlying transcriptional
and epigenetic mechanisms, and (3) define the signaling pathways downstream of p-EMT and discern their
functional importance in tumor behaviors.
Dr. Tim Ley and Dr. Greg Longmore are exceptional mentors with an extensive history of trainees in major
academic positions. Dr. Ley is an internationally renowned leader in oncology, genomics, and tumor biology,
with appointments including Associate Director of the Siteman Cancer and the McDonnell Genome Institute at
Washington University St. Louis (WUSTL), National Cancer Advisory Board Member, and former Chair of Board
of Scientific Counselors for National Institute Genome Research Institute. Similarly, Dr. Greg Longmore is a
world expert in molecular oncology, EMT, and cell biology, with appointments as Co-Director of Molecular
Oncology and Director of the Integrating Communications within the Cancer Environment Institute, WUSTL. An
exceptional Research Advisory Committee (RAC) will provide additional guidance, including Dr. Ting Wang, Dr.
Jose Zevallos, and Dr. Rob Mitra. The K08 award will provide me with the ideal opportunity to succeed in my
career goals. The detailed training plan includes a RAC and development of technical/leadership skills that will
be invaluable for a transition to independence. Research will be carried out at WUSTL, a prestigious research
institute that fosters collaboration, emphasizes intellectual exchange, and boasts unparalleled facilities.

Public health relevance
PROJECT NARRATIVE Despite progress in the understanding of head and neck cancers, including head and neck squamous cell carcinoma (HNSCC), the mainstays of treatment continue to be surgery, radiation, and chemotherapy, with significant morbidity and mortality from metastatic disease and no targeted therapeutics available. This research proposal will investigate the role of tumor invasion and metastasis through in vitro and in vivo studies of partial epithelial-to-mesenchymal (p-EMT) signaling, including its downstream effectors and upstream regulation via cancer-associated fibroblasts. The overarching goal is to better understand and characterize invasion and metastasis in HNSCC and to determine whether targeting components of the p-EMT program may be an effective therapeutic strategy in HNSCC patients.